Data Management and Statistical Core

The Data Management and Statistics Core (Data Core) of the Massachusetts Alzheimer’s Disease
Research Center (MADRC) provides state-of-the-art data management and statistical expertise for the
MADRC and affiliated research studies, for collaborative efforts with other ADRCs, and for national
AD/ADRD research initiatives. The Data Core is an essential component of the MADRC research enterprise
as it facilitates scientific rigor, regulatory-compliance, and strong connectedness across cores within our
Center, and with NACC and others outside our Center. It serves to minimize the burdens of research by
optimizing study efficiencies through subject selection, endpoint selection, facile and adaptive designs, as
well as provides guidance on rigorous study design and analyses. The Data Core provides informatics
expertise and assistance, including data-management, timely data transmission to NACC, and query and
reporting support to all the MADRC Cores.
The Core will play a major role in helping MADRC achieve its overarching goal of understanding
drivers of clinical progression. The Core aims to contribute easily accessible data resources and
statistical expertise to local, regional, national, and international ADRD research (Aim 1); to develop,
implement, and share new statistical, machine learning, and bioinformatics methods to better understand
inter-individual variability in the pace of change. We will utilize data from natural history studies combined
with computational approaches to better understand how new treatment modalities affect clinical progression
and impact research. (Aim 2); to train clinical and translational researchers from diverse backgrounds in
quantitative methods and attract quantitative scientists to ADRD research by collaborating with the Research
Education Component (REC) to train clinical and translational researchers in quantitative methods and to
attract quantitative scientists to AD/ADRD research (Aim 3); and to diversify the Research Cohort and other
ADRD research participants by optimally leveraging data and technology for recruitment into research
studies and clinical trials, as well as to diversify staff and faculty engaged in ADRD data science (Aim 4). We
will freely disseminate our methodological innovations to the scientific community and promote open and
reproducible science through data and software sharing.
The Data Core provides guidance on scientific rigor: it assists MADRC researchers with study design
and ensures valid and accurate analyses of studies across all MADRC Cores. The Data Core also advises
MADRC researchers on data quality, version control and tracking measures. It ensures all systems are
secure and within the Mass General Brigham (MGB) IT Infrastructure. The Core promotes open and
reproducible science by disseminating methodological innovations to the scientific community and through
data and software sharing.